Iron Deficiency in Cystic Fibrosis: Characterization of Clinical Impact and Treatment Effects

PROJECT SUMMARY
Shijing Jia, MD, is a Pulmonary and Critical Care physician at the University of Michigan. This K23
mentored career development application includes a coordinated 5-year plan of training and research activities
designed to advance Dr. Jia toward her long-term goal of becoming an independent physician-scientist
conducting patient-oriented research on cystic fibrosis (CF). CF is a common genetic disorder which has now
been described in people of all races and ethnicities. Iron deficiency is a highly prevalent extrapulmonary co-
morbidity in CF and is reported to affect 30-80% of those with CF. As observed in other chronic inflammatory
disease states with a high prevalence of, like chronic kidney disease (CKD) and inflammatory bowel disease
(IBD), ID in CF has been linked to markers of poor clinical outcomes. However, while the CKD and IBD fields
each have disease-specific diagnostic and treatment guidelines for ID, which include a low threshold for
diagnosis and expeditious treatment via intravenous (IV) repletion, no guidelines exist specific to CF. There is
a critical, urgent need to understand clinically meaningful ID as determined by presently available biomarkers
and provide data on the clinical efficacy of available ID treatments via IV versus oral repletion therapy.
This proposal aims to systemically provide high-impact clinical outcomes data on ID in CF through 1) a
multicenter retrospective cohort study; and 2) a prospective two-center randomized pilot study. In completion of
this project, Dr. Jia will provide evidence on clinically meaningful diagnostic thresholds for ID in CF using
available biomarkers, describe the comparative efficacy and safety of IV and PO iron repletion in CF, and
ultimately use these results to power a multicenter randomized trial of ID treatment in CF. The training plan
includes intensive mentorship by experts in clinical trials (MeiLan Han, MD and Jennifer Taylor-Cousar, MD,
Richard Simon, MD), iron deficiency in CF (Alex Gifford, MD and Angela Weyand, MD), and biostatistics
(Susan Murray, ScD), formal coursework to obtain a Master’s Degree in Biostatistics, professional
development activities, and progressively independent research. Completion of this stagewise training program
will train Dr. Jia to lead future CF trials in subsequent R01, U01, and/or R21 applications. Dr. Jia’s unique
resources include access to a dedicated team of co-mentors, advisors, and collaborators with whom she has
longstanding relationships. The University of Michigan has an outstanding research infrastructure, actively
supports junior investigators, and offers advanced courses and training in relevant disciplines to ensure her
future success as an independent investigator.

Public health relevance
PROJECT NARRATIVE Iron deficiency has a 30-80% reported prevalence in cystic fibrosis (CF), but no existing disease-specific diagnostic and treatment guidelines. This proposal will provide seminal data on the clinical impact of iron deficiency in CF and comparative treatment effects of intravenous versus oral iron repletion, through a multicenter retrospective cohort study and a prospective pilot clinical trial. The data acquired through the completion of this project will power a multicenter randomized controlled trial to provide specific treatment guidance for iron deficiency in CF.